Targeting molecular mechanisms of the adeno-to-squamous transition in non-small cell lung cancer treatment adaptation

SUMMARY
Transdifferentiation is a common mode of cellular plasticity in resistance to targeted therapy, and is observed
histologically across multiple cancer types, including LUAD-to-small-cell lung cancer, enabling resistance to
EGFR inhibitors. There is a growing recognition that the adaptive process taken by cancer to thwart therapy
has a non-genetic component, thus requiring the determination of new avenues of therapy. In LUAD, KRAS
was long thought to be undruggable, however, two inhibitors received FDA approval three years ago. Though
these inhibitors contributed to a response rate of 40% improving clinical outcomes, patients inevitably relapse,
with a subset of the tumors adapting to KRAS inhibition by non-genetic mechanisms. In 2020, members of our
team discovered that in response to one of the KRAS inhibitors – adagrasib – the tumors of a subset of
patients undergo an adeno-to-squamous transition (AST). In this proposal we formulate a comprehensive
research program aimed at dismantling AST as an escape route for cancer to adagrasib treatment, by blocking
its required chromatin regulators and by decoupling it from the induction of resistance programs. In our
preliminary studies, we established mouse and organoid models and found evidence that disruption of specific
chromatin regulators either genetically or pharmacologically modulates cellular state along the AST spectrum.
This has led us to hypothesize that a screen of chromatin remodelers will reveal AST vulnerabilities. In Aim 1,
we carry out a Perturb-Seq screen coupled with a scMultiome approach to identify the specific regulators and
then target these with small molecule inhibitors. Finally, we test the translational potential of these inhibitors to
block the transition in human patient derived xenografts. A second major finding that we address here is that
the squamous histology alone is not sufficient to confer drug resistance to adagrasib, suggesting that additional
molecular pathways are required for the adaptive process. This has led us to hypothesize that drug resistance
is caused by the sequential induction of first the resistance programs and then a lineage state transition. A
prediction of this hypothesis is that distinct lineage states are compatible with unique resistance programs, and
thus we seek to systematically decouple this relationship to reveal the specific dependencies of each lineage
state. In Aim 2, we leverage a dropout CRISPR-method approach to identify regulators of resistance for both
the intermediate and the squamous lineage state along AST, and then we systematically test for the sufficiency
and necessity of both the lineage state and resistance programs in modulating the response to KRAS
inhibition. We then more broadly test for the expression and clinical relevance of resistance programs in
primary human lung adenocarcinoma tumors and how they relate to the host lineage states. Overall the impact
of this research is to identify new therapeutic vulnerabilities of lineage states along AST – an important and
unaddressed clinical problem – by dissecting the relationship between lineage state and resistance programs.

Public health relevance
NARRATIVE Advancements in treating KRAS mutant lung adenocarcinomas have led to the development of novel inhibitors, however their efficacy is limited by the transition to lung squamous histology as a critical drug adaptation mechanism. Both in this context and that of other targeted therapies, lineage infidelity and histological transdifferentiation have been increasingly recognized as important resistance mechanisms though we currently lack a molecular understanding of these cellular plasticity programs. In this proposal, we describe a set of compelling preliminary results that have led us to propose a highly collaborative research program aimed at identifying the causal chromatin-remodelers and resistance programs that underlie the adeno-to-squamous transition in adagrasib treatment.